BCCMA: Overcoming chemoresistance in ovarian cancer: Targeting Unique Vulnerabilities in Neuroendocrine-like Ovarian Cancer Cells

This Collaborative Merit Award application (CMA), consisting of three projects (CMA1-3), addresses a critical
challenge in the clinical management of ovarian cancer (OC). The most common and lethal subtype of OC is
high-grade serous ovarian carcinoma (HGSOC). Standard treatment for HGSOC combines surgical
cytoreduction with platinum-based chemotherapy. Patients diagnosed with HGSOC often suffer from disease
relapse associated with the emergence of chemotherapy resistance. The clinically needed key to increasing
survival in HGSOC is to prevent the development of platinum resistance or identify alternative means of targeting
platinum resistant (PtR) tumors. The main goal of this interdisciplinary and collaborative project is to identify
novel targets and biomarkers of therapeutic efficacy for HGSOC. This requires a better understanding of the
mechanisms that results in transformation of HGSOC cells to an aggressive, therapy-resistant phenotype.
Increasing evidence support the hypothesis that a key contributor to platinum resistance is the reprogramming
of cancer cells into a less differentiated and metabolically adaptable state. This collaborative proposal by three
established OC researchers will leverage their interdisciplinary expertise and resources to define new
mechanisms of resistance in OC. CMA1 will use spatial profiling and systems biology to provide a holistic
understanding of PtR as well as prioritize cell-intrinsic and microenvironmental clinically relevant underlying
molecular pathways. Preclinical immunocompetent mouse models and co-culture models will be used to study
the role of the tumor microenvironment in PtR. CMA2 will study metabolic adaptation associated with the
emergence of PtR focusing on a shift to fatty acid oxidation in PtR HGSOC tumors CMA2 will use resources
shared with CMA1&3 and cellular biology and single cell metabolic imaging to define unique metabolic
dependencies of PtR HGSOC. As PtR tumors are susceptible to death induced by oxidized lipid membranes,
mechanisms of ferroptosis will be examined in PtR models treated with novel metabolism targeting agents, which
will be tested with CMA1. CMA3 will explore the reprogramming of recurrent HGSOC cells into more tumor
subpopulations with neuroendocrine (NE)-like features. Mounting evidence in other tumors suggest progression
to a NE-like state results in therapy resistance- a concept yet to be explored in OC. To identify NE-like cells in
OC, the transcriptome, proteome, gene vulnerability, and drug sensitivity landscape of matched patient tumors
and model systems will be evaluated for emergence of NE-like cells under chemotherapeutic pressures. Data
emerging from the analysis of patient tumor samples in this proposal in addition to existing drug dependency
databases will be mined for identification of druggable targets in NE-like cells. Drugs effective against these cells
will be tested alone or in combination with carboplatin in targeting PtR OCs. Hallmarks of NE-like cells including
metabolic adaptations and histologic characteristics will be explored with CMA2 & CMA1 respectively.
Rationale: Recent work demonstrates that many epithelial cancers converge to more aggressive state with
genetic hallmarks and characteristics of NE-like cells. Histologic analysis, the original standard for defining
neuroendocrine phenotypes, of recurrent ovarian tumors supports emergence of NE-like cells. Our preliminary
bulk RNA sequencing data from longitudinally collected ovarian tumor samples, further supports chemo-induced
progression to an NE-like state based on our previously published NE gene expression signatures. Pan cancer
data has revealed that NE-like cells are more aggressive and resistant to chemotherapy. This is why
understanding the molecular underpinnings of NE-like cells in ovarian cancers is critical. We hypothesize that
eradication of PtR disease, requires additional therapeutic approaches that are directed to target NE-like cells in
ovarian tumors. CMA3 plans to mechanistically define vital pathways for survival of PtR NE-like tumor cells and
test drugs that can eliminate this tumor subpopulation. We envision our work will result in immediate clinical trial
designs that can test new approaches for treating OC patients.

Public health relevance
This Collaborative Merit Award application (CMA) is a synergistic, multidisciplinary project focused on the mechanistic understanding of platinum resistance as the foremost cause of death in ovarian cancer patients. The overall strategy is to integrate ideas, resources, and expertise in advanced technologies to identify novel therapeutic targets and biomarker-driven treatments for ovarian cancer patients. CMA3 is focused to investigate the reprogramming of recurrent HGSOC cells to a more aggressive and therapy resistant tumor subpopulation with neuroendocrine (NE)-like features. Studies in this project will define the characteristics and molecular pathways activated in NE-like cells while simultaneously exploring unique vulnerabilities that can be exploited therapeutically with drugs poised to target NE-like cells. Aims of this proposal using human ovarian cancer samples and innovative precision medicine approaches have the potential for immediate translation into future clinical trials.